Electronic Pediatric Office Systems to Support Treatment for Parental Tobacco Use

Project Summary/Abstract
When parents quit smoking, their life expectancy is increased by an average of over 10 years, future tobacco-
related poor pregnancy outcomes are eliminated, their children have much lower odds of becoming adult
smokers, and their children may no longer be exposed to high levels of tobacco smoke, decreasing the odds of
contracting diseases caused by tobacco smoke exposure and resulting in fewer missed school days. Helping
parents and household members quit smoking also improves the financial resources of families, decreases the
risk of developmental delays, and lowers the risk of house fires. Parents who smoke are often medically
underserved, visiting their child's healthcare provider more often than they see their own clinician, if they even
have one. Despite this extraordinary opportunity for intervention, child healthcare settings deliver effective
tobacco dependence treatment to parents less than 2% of the time. Routinely delivered tobacco control to
parents in child healthcare settings would benefit the overall health of the nation. The goal of the proposed
study is to ensure that every parent who smokes tobacco or is a dual user of tobacco and e-cigarettes
and visits their child's doctor receives evidence-based assistance to quit. We propose testing an
innovative EHR systems platform (iEHR) in pediatric practices. The iEHR will facilitate universal screening
for household tobacco use and routine offering and provision, if desired, of tobacco cessation services. We will
compare this intervention to iEHR + navigator to test the effectiveness of additional support by a community
health navigator. The navigator will work with pediatric offices to assist household tobacco users in cessation
through telephone follow-up, ensuring access to services, and home visits, based on what they want to help
them quit smoking. This trial will address critical unanswered questions of effectiveness, sustainability, and
cost-effectiveness of a parental tobacco cessation intervention that supports delivery of tobacco cessation
services using iEHR, with or without a navigator. This proposal is in exact alignment with NCI's objective to
fund research to reduce the burden of cancer for patients and other affected persons through improvements in
early detection, prevention, healthcare delivery, quality of life, and/or survivorship related to cancer. Aims are:
A1. To compare parents' combusted tobacco quit rates, and adoption of tobacco free behaviors between the
two intervention arms (1°: iEHR+Navigator vs. iEHR; 2°: each intervention vs. usual care control)
A2. To establish the incremental cost per quit of the two intervention arms vs. usual care control
A3. To assess the delivery and sustainability of the interventions
Building on the success of past trials, this application will evaluate an innovative EHR-linked tobacco
cessation intervention addressing household tobacco use with and without navigator support. The
study is designed to yield fully-integrated, cost-effective, disseminable, and sustainable strategies to
optimize parental cessation outcomes throughout child healthcare settings nationally.

Public health relevance
Project Narrative The objective of this research is to transform tobacco control treatment delivery in child healthcare offices by testing the effectiveness of an innovative EHR systems platform (iEHR) with and without the additional support of a community health navigator. The newly developed iEHR will facilitate universal screening for all household members who smoke tobacco or are a dual user of tobacco and e-cigarettes, and provide default tobacco cessation assistance to parents by generating nicotine replacement therapy prescriptions and referrals to free resources (quitlines). Data on the cost-effectiveness of these approaches will help decision makers choose which intervention to implement in their organizations.